In Vivo Synaptic Imaging in Neocortex

ABSTRACT
Synapse addition and loss have been linked to learning throughout the brain. This has been
well-documented in the neocortex using anatomical analysis of axonal boutons or dendritic
spines in both fixed tissue and in vivo, using longitudinal imaging. However, it has been difficult
to extrapolate the consequences of these synaptic changes without understanding how they lie
within a defined network of cell-type specific contacts, requiring identification of the pre- and
postsynaptic partners of the synapse. Here we will use in vivo imaging and multicolor
fluorescence labeling of molecularly-defined pre- and postsynaptic neurons to monitor input-
specific synapse addition and loss during sensory learning in a whisker-dependent task in mice.
Synaptic contacts will be validated using post-hoc expansion microscopy and
immunohistochemistry for nanoscale resolution. Analysis will be focused on learning-dependent
reorganization of thalamic inputs from a higher-order thalamic nucleus, the posterior medial
nucleus (POm) onto the dendrites of layer 5 (L5) pyramidal neurons that have been specifically
implicated in experience-dependent plasticity. Quantitative, multicolor, in vivo imaging across
different stages of learning will provide insight into how cortical circuits encode and are changed
by salient sensory information.

Public health relevance
NARRATIVE Although experimental evidence indicates that synapses reorganize during learning, anatomical studies have focused on isolated pre- or postsynaptic changes making it hard to understand how specific neural circuits are altered by experience. We will use multicolor fluorescence in vivo imaging to link pre- and postsynaptic partners and track how these specific contacts are changed during sensory learning in the living brain. These studies will reveal how neocortical circuits and information processing are altered by experience and will identify new avenues for treatment of learning and memory disorders.